Vascular contributions to cognitive impairments and dementia (VCID) among people living with HIV in the country of Georgia

Limited knowledge exists about vascular contributions to cognitive impairments and dementia
(VCID) among PLWH or older adults without infection in the Eastern European and Central
Asia (EECA) region including Georgia. The intersection of VCID with the HIV care continuum
has never been estimated in Georgia and the EECA, and not evaluated among PLWH who
are living to older ‘at risk’ ages. To mitigate adverse effects of VCID among PLWH, the
prevalence of VCID and other aging-related risk factors must be estimated and characterized
across the HIV care continuum. This application is a supplement to Fogarty HIV Research
Training Grant (1D43TW011532; Strategic Training Partnership to End AIDS in Georgia).
We propose to address the surging ‘HIV + noncommunicable disease (NCD)’ care continuum
in Georgia. Early Stage Investigator (ESI) training will be operationalized via: Aim 1. Advanced
didactic training in HIV-aging, VCID measures, and brain health outcomes; and Aim 2. Hands-
on training in research project development, implementation and analysis via conducting a
cross-sectional pilot study of 150 PLWH age >40 years. Among these participants, the goals
of the pilot study are to: Aim 2.a. Characterize sociodemographic and HIV (e.g., HIV viral load,
CD4+ count) factors; Aim 2.b. Estimate the prevalence of VCID and brain health using pilot
study measures. VCID include obesity, hypertension, Type 2 diabetes, and hyperlipidemias;
history of cardio- and peripheral vascular events; cigarette smoking; alcohol use; and
substance abuse. Brain health outcomes include cognitive performance and impairment,
severity and clinically-relevant depression and anxiety symptoms, and history of
cerebrovascular disease and stroke. Aim 2.c. Evaluate VCID risk and history with stratification
by HIV severity (viral load and CD4+ count), HCV coinfection (yes/no), injection drug use
(yes/no), 10-year age group, and sex and gender. This innovative pilot study is the first in
Georgia and the EECA region among aging PLWH that uses standardized and validated
clinical and blood-based biomarker approaches. Our results will inform development of
interventions to reduce VCID and adverse brain health outcomes related to the HIV+NCD care
continuum among PLWH; and prospective observational studies to compare aging processes
between PLWH and people without HIV infection. These future deliverables will be achieved
through HIV research capacity building of one Georgian ESI, a recent doctoral graduate, who
will receive advanced didactic and hands-on training in the development of a strategic skillset.

Public health relevance
Vascular contributions to cognitive impairments and dementia (VCID) are virtually unknown in people living with HIV infection (PLWH) who are surviving to ages when they will be at risk for late-onset dementia, including Alzheimer’s Disease. Communicable and noncommunicable comorbid diseases, and lifestyle and behavioral factors exacerbate vascular risk, and these data are lacking among PLWH in Eastern Europe and Central Asia including the country of Georgia. We propose advanced didactic and hands-on training of one early stage Georgian investigator to build HIV research knowledge and implementation capacity by collecting VCID data in Georgia for the first time among PLWH who are >40 years in Georgia.